Receptor kinase signal integration in stem cell maintenance and development.

The project is requesting funds for a Leica EM CPD300 automated Critical Point Drying
system for preparing plant tissue samples for Scanning Electron Microscopy. This proposal
supports R35GM119614 which aims to understand the role of CLE peptide signaling in stem cell
regulation and development in plants. SEM has been instrumental in ultrastructural analysis of
plant tissues in this project, however the lack of critical point drying equipment has limited the
scope of tissue types that can be analyzed. As such Leica EM CPD300 will enable the imaging
of delicate and easily desiccated plant tissues rapidly and in a high throughput manner and will
assist the analysis of the processes CLE peptides play in plant development.

Public health relevance
This proposal seeks additional instrumentation to assist in the imaging and analysis of mutants in genes that regulate plant stem cell maintenance and development. Studying the signaling genes that govern plant development and stem cell niche function will allow us to compare mechanisms across animals and plants and elucidate the suite of possibilities and principles underlying signaling and development in eukaryotes.